Harvard Education Program in Cancer Prevention Control

Program Summary
The Harvard Education Program in Cancer Prevention and Control, in its 24th year, is a dynamic transdisciplinary
collaboration that brings together the extensive expertise of the Harvard T.H. Chan School of Public Health, the
Dana-Farber Cancer Institute and Dana-Farber/Harvard Cancer Center, and Harvard Catalyst |The Harvard
Clinical and Translational Science Center. We have trained 116 (60 predoc, 56 postdoc) fellows in
transdisciplinary approaches to cancer prevention and control, and 88% of trainees currently hold a research-
focused position. In this renewal, we are requesting continued support for 4 predoctoral and 4 postdoctoral
trainees each year who have an average length of training of 4 years and 2 years respectively. The overall goal
of the Program is to train fellows to become the next generation of scientists who are: (1) knowledgeable about
the current state of the science of cancer prevention and control; (2) skilled in transdisciplinary research; (3)
skilled in formulating and writing research proposals and scientific manuscripts for publication; and (4) anchored
in peer and professional networks that support continual professional development and access to resources to
translate their knowledge into new cancer research areas. Transdisciplinary training will be further enhanced by
leveraging a new transdisciplinary PhD program in Population Health Sciences that integrates training in five
public health disciplines, and by instituting a new approach to mentorship – known as developmental networks
– which creates diverse mentoring teams. We have also added new indicators of transdisciplinary training into
our evaluation plan. We have identified 5 focal areas in which trainees will receive robust training and research
experiences, including: (1) cancer disparities; (2) global cancer prevention; (3) implementation science; (4) health
communication; and (5) population health science. Robust and engaged internal and external advisory
committees, and 25 very strong mentors with extensive research portfolios ensure that the program will continue
to thrive and innovate in cancer prevention training. The maturity of this Program, extensive resources available
through Harvard and synergy across the focal training areas provide an outstanding platform for training the next
generation of cancer prevention scientists.

Public health relevance
Project Narrative This training program is in its 24th year, and has trained 116 fellows in transdisciplinary approaches to cancer prevention and control. Eighty-eight percent of trainees currently hold a research-focused position. The maturity of this Program, extensive resources available through Harvard and synergy across the focal training areas provide an outstanding platform for training the next generation of cancer prevention scientists.